A dynamic synaptic sensor controlling hippocampal CA3 circuit function

Summary:
Moment-to-moment changes in synaptic strength are a dynamic property of many synapses including in
regions of the brain known to be important for episodic memories. In the hippocampus synaptic transmission at
mossy fiber (MF) synapses between dentate gyrus (DG) granule cells and CA3 pyramidal cells, displays a
large dynamic range of release that acts as a high pass filter for activating CA3 neurons during high frequency
bursts in the DG. It has been proposed that the MF connection is a teaching signal that is critical for the ability
of the CA3 network to encode the details necessary to separate similar instances as distinct episodic
memories. Despite the potential importance of MF synaptic facilitation to the separation of similar patterns,
direct empirical evidence for this has been lacking. The goal of this proposal is to test how the unique dynamic
properties of MF synapses contribute to the ability of an animal to distinguish similar spatial representations.
We will take advantage of the finding that a specialized presynaptic Ca2+ sensor, with high affinity and slow
kinetics, is the key to the large activity-dependent facilitation of release of neurotransmitter at MF synapses.
We propose that elimination of this sensor in MF synapses in a newly created conditional knockout animal will
1. alter the dynamics of the MF synapse, 2. disrupt the high pass filter properties of the CA3 circuit and 3.
ultimately impact specific cognitive processes that impair the ability of mice to separate similar patterns in
space. This short, focused project is designed to test a circumscribed question that will explicitly establish
whether MF synaptic dynamics can map onto cognitive processes that underlie pattern separation.

Public health relevance
Project Narrative: Rapid fluctuations in the strength of synaptic connections in the brain underlie the complex patterns of neural activity which drive all behaviors including those that require the retrieval of stored information in memories. Therefore, understanding how synapses operate is crucial to our understanding of cognitive deficits associated with aging and aging-related neurological disorders. In this project we will determine how the properties of synaptic connections directly map onto cognitive processes that allow us to separate similar instances in episodic memory.